Integrated Musculoskeletal Training Program

PROJECT SUMMARY
Musculoskeletal diseases and injuries such as osteoarthritis, osteoporosis, tendinopathy,
intervertebral disc degeneration and many more continue to be the leading causes of disability
worldwide, imposing an enormous socioeconomic burden on the health care system in this
country. This era has also ushered in paradigm-shifting scientific revolutions in tissue and
regenerative medicine, in vivo and ex vivo disease modeling, sequencing and genomics, high-
resolution imaging and biomechanics. These developments at the bench side require
multidisciplinary expertise in science, engineering, and medicine to continue to accelerate the
trajectory of musculoskeletal research to ultimately address unmet clinical needs at the bedside.
However, research training in musculoskeletal research continues to be largely siloed into single
discipline approaches and settings. In this application, we propose a new Integrated
Musculoskeletal Training Program (IMTP) that brings together world leading musculoskeletal
researchers and clinicians at Columbia University with expertise in biomedical engineering, cell
and molecular biology, pathology and cell biology, mechanical engineering and innovation. This
unique predoctoral training program focuses on integrating the multiple disciplines required for
cutting edge research training of the next generation of scientists and engineers in the field. The
proposed T32 training program will establish a unique training paradigm in musculoskeletal
disease, with the following required training elements: (1) clinical preceptorship in musculoskeletal
medicine (orthopaedic surgery, physical medicine and rehabilitation, rheumatology, radiology,
etc.), (2) mandatory co-advising by a team consisting of a bioengineer, biologist, and a clinician,
(3) innovation and design training for identifying clinical needs and gaps in knowledge /
technology, and (4) training in diversity and equity challenges. This T32 training program will
provide a unique and timely opportunity to promote, enhance, and deepen multidisciplinary
musculoskeletal research by supporting trainees with the skills and the values needed to enter
the biomedical research workforce and to solve the complex problems of musculoskeletal disease
in the future.

Public health relevance
PROJECT NARRATIVE The proposed new pre-doctoral Integrated Musculoskeletal Training Program aims to provide a unique and timely opportunity to promote, enhance, and deepen multidisciplinary musculoskeletal research by supporting trainees with the skills and the values needed to enter the diverse biomedical research workforce and to solve the complex problems of musculoskeletal disease in the future.